Protocol Review and Monitoring System

The Scientific Review Committee (SRC) ensures that all cancer-relevant interventional trials conducted under the auspices of Vanderbilt-Ingram Cancer Center (VICC) are of the highest scientific quality, follow responsible conduct of research principles, and have significant potential impact for patients. In addition, there is an intentional focus to develop a portfolio of interventional trials that meet the needs of the catchment area and ensure inclusion of participants across the lifespan. Protocols requiring full committee review are evaluated for appropriate scientific rationale, clearly defined specific aims, achievable study endpoints, research integrity, a plausible biostatistical plan, feasibility, and a well-justified ability to accrue eligible patients from the VICC catchment area. These criteria exist to ensure that the study design supports the completion of its scientific goals. This focus on the scientific integrity of the trial clearly sets the SRC’s role apart from the Vanderbilt Institutional Review Board (IRB), in that the SRC is focused on sound science with potential of translation to cancer care, while the IRB is primarily concerned with patient safety. The SRC and IRB have two separate functions and yet both complement each other by ensuring the integrity of the study through a sound scientific approach while also considering the protection of all participants. The IRB does not play a role in determining the extent of Cancer Center support that a protocol should receive. However, the SRC is responsible for prioritizing each protocol and providing recommendations regarding Cancer Center support, which includes CTO work queue management and financial support for institutional trials or those not fully funded by an extramural sponsor.
In addition to ensuring a high level of scientific merit and appropriate prioritization of VICC interventional trials, the SRC oversees the progress of all active interventional protocols by routinely monitoring the patient accrual and closing studies that do not demonstrate scientific progress and adequate accrual. Low accruing studies involving rare diseases and studies that advance key areas of focus and align with the Cancer Center’s strategic plans will be given special consideration. The SRC will also review any protocol changes that have a significant impact on the design or scientific rationale for an ongoing interventional trial.

Public health relevance
The Protocol Review and Monitoring System (PRMS) functions are maintained at the Vanderbilt-Ingram Cancer Center (VICC) by the Scientific Review Committee (SRC). The SRC ensures a high level of scientific merit and appropriate prioritization of VICC interventional trials and oversees the progress of all active clinical trials by routinely monitoring the accrual to all Cancer Center protocols. The SRC also oversees the status of all active clinical trials through routine monitoring for any protocol changes which may have a significant impact on the design or scientific rationale for the clinical trial. The SRC is co-chaired by Michael Gibson, MD (TR), and Muhamed Baljevic, MD (TR). Starting in 2015, the SRC’s highly engaged and experienced leadership expanded and enhanced the membership to bring more senior-level expertise to cancer- relevant studies conducted across the cancer continuum. The SRC co-chairs work in conjunction with physician leaders of the disease-specific cancer teams in order to identify and evaluate VICC members for SRC membership when new members are needed. The goal of the nomination and evaluation process is to select individuals who will bring specific expertise and experience to the Committee thereby ensuring the SRC provides review in all areas relevant to the scientific design and responsible conduct of interventional trials. Specific Aim 1: To provide a rigorous scientific review and prioritization of all cancer-relevant interventional trials at VICC. SRC reviewers consider the trial’s scientific rationale, study design, expected accrual rates, biostatistical plan and feasibility for completion in order to insure rigorous consideration of the scientific merit, rigor, reproducibility, and impact. The SRC has the ultimate responsibility for providing a formal prioritization across VICC’s entire portfolio of trials based on scientific merit and accrual goals. These considerations for study priority are captured within the eSRC portal during the SRC meetings. The disease team leaders inform the SRC prioritization process by providing information on feasibility and the disease team’s priorities in the eSRC application. Specific Aim 2: To monitor clinical trials for scientific progress, impact and patient accrual. The SRC oversees the status of all active clinical trials through routine monitoring for accrual and any protocol changes, which may have a significant impact on the design and/or scientific rationale for the clinical trial. The SRC regularly evaluates its standard operating procedures and ensures alignment with the changing environment of clinical trials and the expansion of the VICC catchment area. The PRMS, as executed at VICC by the SRC, will continue to evolve to best serve the needs of individuals who benefit from VICC research both within and beyond the catchment area. Importantly, the SRC supports clinical researchers in designing rigorous clinical trials with experimental approaches that will have high impact, while ensuring transparency and reproducibility. SRC faculty and staff are particularly well placed to facilitate appropriate experimental design and validated methods, ensuring statistical power, and in defining and establishing rigorous methods for acquiring clinical data and analyzing tissues. The SRC, through sharing of best practices, enables individual investigators, students, nurses, fellows and staff to better incorporate these practices into their clinical trials. Mentoring investigators and trainees toward best practices is a key feature of the SRC iterative approach to ensure the highest impact from our clinical research.